SYNTHESIS OF AMINO ACID-DERIVED NATURAL PRODUCTS

Chemical synthesis provides the capacity to produce chemotherapeutic agents, and chemical reactions are the irreplaceable tools of the medicinal chemist engaged in the drug discovery process. Advances in chemical reaction technology reduce the interval between the conception of the chemical entity as a potential drug candidate and its synthesis for subsequent biological evaluation. As a consequence, the synthesis activity is a critical discipline which continues to have an important impact upon the fields of both medicine and biology. The present grant will continue to address the development of new stereoselective reactions which are relevant to the synthesis of antibiotic and antineoplastic agents derived from amino acid constituents The methodological studies dealing with new reaction discovery will emphasize the development of chiral metal catalysts for the catalyzed aldol and imino-aldol reactions of glycine enolates and the catalyzed variant of the Strecker reaction. These advances should culminate in practical routes to the asymmetric synthesis of hydroxy-alpha-amino acids and alpha,beta-diamino acids as well as alpha-amino nitriles. In closely related studies, we will utilize chiral metal catalysts to promote the enol insertion of metal nitrenoids as a method for the asymmetric synthesis of alpha-amino acids through enol amination. These reactions will be incorporated into projects whose focus is the synthesis of amino acid-derived natural products. Some of the synthesis objectives will include the development of an asymmetric synthesis of the cephalosporin, carbacephalosporin, and oxacephalosporin antibiotics through catalytic asymmetric synthesis methods. We will also determine the structure and develop an asymmetric synthesis of the hexapeptide complestatin, the most potent inhibitor of the human complement system. We will also address the structure determination and synthesis of diphthamide, the most complex amino acid yet isolated. This histidine-derived amino acid is an essential constituent in elongation factor-2, the protein responsible for translation during protein synthesis. The diphthamide moiety is intimately involved, in some as yet undefined way, in the function of this protein. Collaborative studies will be pursued to more closely define the role of diphthamide in protein synthesis.